New approach for identification pHFO networks to predict epileptogenesis

PROJECT SUMMARY
Epilepsy is among the most common serious neurological disorders, and about 40% of epilepsy patients do not
respond to existing treatment. Clinically, the prolonged, refractory epilepsy with negative surgical outcomes is
often associated with distributed epilepsy onset rather than a local epileptogenic zone. Understanding the
epilepsy as a large-scale brain network abnormality enables the development of new treatment options and
research directions. At present, the majority of research related to analysis of the epileptic network has been
focused on the ictal period, while few have been devoted to the analysis of the earlier stages of epileptogenesis
(latent period). Investigating the brain network properties of epileptogenesis is as important and can help
develop antiepileptogenic interventions for epilepsy prevention and cure. Early in our experiments, we
discovered pathological high-frequency oscillations (pHFOs), which are reliable biomarkers of epileptogenesis.
They are generated by clusters of pathologically interconnected neurons (PIN-clusters) and reflect bursts of
population spikes. Recent updates in the animal models of chronic epilepsy evidenced the spatially distributed
pHFO events, which implies the development of large-scale PIN-cluster networks during epileptogenesis. It is
critical to study the network topology and characteristics of PIN-cluster-formed epileptogenic networks in
order to further understand the underlying mechanisms of epileptogenesis.
To fulfill this gap, the present study plan is to explore pHFO-based networks using the Kainic Acid (KA)-
induced status epilepticus (SE) model of epileptogenesis. We hypothesize that epileptogenesis after SE is
dependent upon the formation of large-scale PIN-cluster networks that is expressed by the spatial occurrence
and temporal coupling of pHFOs. Combining the biocompatible, organic–material based neural interface array
(NeuroGrid) with multichannel silicon probes, we aim to identify the spatial and temporal profiles of pHFOs
(Aim1). Using the advanced computational algorithms such as graph theory analysis and Shannon Entropy
(SE), we propose to investigate the causal relationship and characteristics of the pHFO-based epileptogenic
networks (Aim2). The outcome of this study will assess the robustness of novel network-based recording design
and algorithm development. It will also determine whether the pHFO-derived network parameters are a
reliable biomarker of epileptogenesis. The future plans are to translate the pHFO-network concept and
computational tools into the clinical study of epilepsy. This approach may open a new direction to the
prevention of epilepsy development and cure epilepsy.

Public health relevance
PROJECT NARRATIVE About 40% of epilepsy patients fail to control seizures after treatment, and there is currently no treatment that can prevent epilepsy. The goal of this study is to perform multi-scale electrophysiological investigations combined with advanced computational algorithm development to understand the characteristics of the pathological brain networks during the latent period of epilepsy. The findings of this project will lead to a better understanding of the network mechanisms of epileptogenesis and suggest novel approaches to prevent the process of epileptogenesis.